Visual Olfactory Learning in Mosquitoes

Summary
Mosquitoes rely on a combination of sensory cues to locate their hosts, including olfactory, heat, and visual
stimuli. Previous studies have shown that olfactory cues play a crucial role in mosquito behavior, but
emerging evidence suggests that visual cues are also important, particularly in the final stages of host
localization. While significant research has focused on the role of olfaction in mosquito host-seeking
behavior, the contribution of vision remains less understood. This proposed research seeks to address this
gap by investigating our working hypothesis that bimodal visual-olfactory stimuli elicit more robust
behavioral and neural responses from mosquitoes – eventually leading to altered blood-feeding
choices. We will test several hypotheses regarding the role of visual and olfactory integration in mosquito
behavior and neural processing. Specific Aim 1 investigates the multimodal learning and memory of
visual and olfactory stimuli, including host-related cues, in the Yellow Fever Mosquito, Aedes
aegypti. This aim will utilize an aversive conditioning paradigm with two testing assays - a two-choice T-
maze and a free-flight blood-feeding choice assay, in addition to neurogenetic sensory knockout lines to
characterize the interplay between olfactory and visual inputs in mosquito responses. We will determine
how aversive learning affects mosquito attraction towards human host odorants and visual wavelengths
(1a) and will test the hypothesis that olfaction is the primary driver of learning performance, with visual
stimuli enhancing those responses (1b). Specific Aim 2 will investigate the encoding of learned and
unlearned host-related visual and olfactory stimuli in the A. aegypti mushroom body (MB), an crucial
sensory learning and integration center in the insect brain. Using 2-photon calcium imaging, we will record
neural activity in the mushroom body Kenyon cells and dopaminergic neurons in response to olfactory,
visual, and bimodal stimuli. This aim will test the hypotheses that KCs exhibit increased activity in response
to host-related cues (2a) and that PPL1 dopaminergic neurons will increase their activity following aversive
associative conditioning (2b). This comprehensive examination of visual-olfactory sensory encoding in a
vector species will significantly advance our understanding of the neural bases of mosquito learning and its
implications for host selection. Additionally, the completion of the proposed aims will provide the first
evidence of visual-spectral learning in mosquitoes and the first recordings from the mosquito MB.
Carrying out these experiments will provide me with training in calcium imaging, neurogenetic techniques,
and data analytical approaches. We are confident that the collaborative environment at the University of
Washington, along with my mentor's experience in training successful scientists, puts me in an ideal
position to achieve these aims and gain the necessary training for my future career.

Public health relevance
Narrative Our understanding of mosquito host-seeking behavior has focused primarily on olfaction; however, the role of vision and the integration of olfactory-visual information remains underexplored. This project combines behavioral assays with advanced neurogenetic and imaging techniques to investigate the neural mechanisms of olfactory-visual integration in mosquito learning circuits and its influence on blood-feeding behavior. The outcomes of this research will provide valuable insights into mosquito host-choice and inform new approaches to disrupt disease transmission.